Texas A&M Center for Environmental Health Research (TiCER)

Administrative Core ABSTRACT
The Administrative Core will provide leadership and guidance to the Texas A&M Center
for Environmental Health Research (TiCER) to ensure excellence of research integration,
community engagement, research translation, and career development. The overall
theme of the Center is “Innovative solutions for addressing exposure-stressor
interactions”. The Administrative Core will serve as the focal point for the Center and
provide the support infrastructure to promote cross-discipline interactions among all
members, facility cores, and external stakeholders. The Administrative Core will be
physically located in the College of Veterinary Medicine & Biomedical Sciences located
on the Texas A&M University campus in College Station. The overall strategy of the
Administrative Core will be to facilitate regular interactions among Center members, track
products and outcomes, develop and plan future activities, and guide and sustain growth
of environmental health research at Texas A&M. The Executive Committee (EC) of the
Administrative Core will coordinate tracking Center progress during monthly meetings.
The EC, along with facility core directors and theme leaders, will form a Program
Committee that will meet quarterly and be responsible for: (i) planning Center activities;
(ii) evaluating progress and considering solutions for challenges; (iii) improving Center
integration; (iv) advising on personnel matters; (v) assessing quality
management/assurance; (vi) organizing the annual retreat; and (vii) evaluating
community engagement, training, and research translation activities. An Internal Advisory
Board (IAB) consisting of senior university leadership will advise the Center in matters of
internal organization. Scientific oversight of the Center will be the responsibility of an
External Advisory Board (EAB), which will meet annually in conjunction with the Center
retreat to perform program evaluation of the Center and determine whether research,
outreach, career development, and translation goals and objectives are being met. The
goals of the Administrative Core will be achieved through four aims: 1) Provide effective
center leadership; 2) Maintain an active membership; 3) Enhance coordination,
integration, and translation of research; 4) Promote career development.